Investigating Platelet Immune Mechanisms in Sickle Cell Disease

PROJECT SUMMARY/ABSTRACT
This proposal describes a rigorous training program for the career development of Dr. Sean Gu, an academic
clinical pathologist specializing in hematopathology. The proposed research builds upon the candidate’s previous
research and clinical experiences. Under the guidance of a multidisciplinary mentorship team led by his primary
mentor, Dr. John Hwa, the comprehensive training plan outlined in this proposal will provide Dr. Gu with the
knowledge and skills necessary to become a successful and independent physician-scientist.
Sickle cell disease (SCD) is one of the most common inherited blood disorders with an estimated 300,000 infants
born globally each year, and in the United States alone, affecting approximately 100,000 individuals. SCD is a
multisystem disorder characterized by remarkable phenotypic complexity with debilitating complications.
Excessive platelet activation has been consistently observed in SCD patients; however, clinical trials have failed
to show significant benefit of conventional antiplatelet therapies in preventing SCD vaso-occlusive disease.
Therefore, a better understanding of the cellular and molecular mechanism that drive platelet alterations in SCD
can lead to more selective and effect strategies.
In this proposal, the candidate proposes to employ novel high-throughput methods to characterize the
heterogeneous states of platelets in SCD. By analyzing blood specimens collected from SCD patients and
utilizing transgenic mouse models of SCD, the candidate will address 1) how distinct platelet subpopulations
contribute to SCD vaso-occlusive disease and 2) investigate specific immunothrombotic pathways and
mechanisms of platelet activation and dysfunction in SCD. The knowledge gained from these studies will
advance our understanding of SCD disease pathogenesis and provide opportunities for developing novel
targeted therapies.

Public health relevance
PROJECT NARRATIVE Sickle cell disease is one of the most common inherited blood disorders and is a complex disease that can have debilitating consequences. Using blood samples collected from sickle cell patients and genetically modified mice, this study aims to understand how platelets contribute to blood vessel occlusion during sickle cell crisis. The findings from this study can offer valuable insights to improve therapies.